Highly Multiplexed Single Molecule Tethering

Highly Multiplexed Single Molecule Tethering
Summary
Bloodstream infections in patients with sepsis symptoms should be promptly treated with
antibiotics; however, the time required to identify pathogens using methods based on blood
culture is a major obstacle to timely effective antimicrobial therapy. The development of a
comprehensive molecular assay capable of identifying microbes directly from whole blood has
been elusive despite major efforts due to the low concentration of microbes in the bloodstream
and the large number of microbial species that cause bloodstream infection (200+). We have
developed an automated assay that detects 13 bloodstream microbes directly in whole blood at
the low concentrations found in clinical samples, with LODs between 0.5 and 3 CFU/mL and a
turnaround time of 70 minutes. The assay performance is superior to other FDA cleared assays
for bloodstream pathogen detection. The new assay is based on Single MOLecule Tethering
(SMOLT), a novel sample preparation and amplification-free molecular detection technology
developed at Scanogen. Here, we propose to dramatically increase the multiplexing capacity of
SMOLT using a novel approach with the goal of producing a panel that covers the organisms
responsible for more than 99% of bloodstream infection cases (Aim 1). We will also integrate the
automated assay into a single disposable cartridge that will be processed by an easy-to-use and
fully automated desktop instrument (Aim 2). We will evaluate the new assay in pilot clinical studies
where we will directly compare the performance of the new assay to the standard of care
diagnostic test based on blood culture followed by mass spectroscopy (Aim 3). Each of these
specific aims has quantitative milestones.
Our long-term goal is the development of an FDA-cleared and CLIA-waived system; this project
is a critical step towards that goal. We will address the challenges of achieving the required level
multiplexing and assay integration, which are the most serious risks on the path to developing the
clinical system. We will work with a multidisciplinary team that includes experts in assay
development and instrument development, including the former Vice President of Engineering at
Becton Dickinson, experts in microbiology, sepsis diagnosis and treatment from Johns Hopkins
University and the University of Pittsburgh, as well as engineers from Key Technologies. After
completing this project, we will further optimize the system for usability and manufacturability and
conduct analytical and clinical studies for submission to the FDA. If successful, the new
automated assay can become part of the standard procedure for the diagnosis of patients
suspected of having sepsis. The new highly multiplexed assay will be useful in other applications
where rapid, cost-effective, and highly multiplexed molecular detection is needed.

Public health relevance
Project Narrative We propose the development of a highly multiplexed and automated molecular platform capable of detecting 90+ targets directly in whole blood in under 70 minutes with high sensitivity and specificity. If successful, the system will have broad applicability in biomedical applications. We will use the new platform to develop a diagnostic assay that responds to the urgent need for rapid identification of bloodstream pathogens in patients suspected of sepsis.